Principles in Pulmonary Research

Project Summary
The Washington University Program in Principles of Pulmonary Research provides multidisciplinary training for
predoctoral and postdoctoral scholars committed to a career in pulmonary research. The postdoctoral portion
of the Program enables MD and MD/PhD physicians who are training in pulmonary and critical care medicine
to learn state-of-the-art scientific research in concert with PhD trainees from a basic science background. The
predoctoral portion of the Program engages students in the M.D., Ph.D. and Ph.D. graduate division to work in
close connection with the same pulmonary research curriculum. The proposal remains at seven postdoctoral
and five predoctoral trainees with 2-3 years of support before transitioning to additional career development
awards. The aim of the Program is to promote the career development of trainees so they will enter academic
pulmonary medicine with the skills needed to study problems relevant to lung biology and disease. The
Program is closely monitored through a Director and four Committees (Diversity Recruitment, Program Review,
Internal Advisory, and External Advisory) and relies on 32 senior mentors, 10 junior mentors, and 16 support
faculty distributed into a coordinated set of three interdisciplinary research tracks, including two basic-
translational tracks (Immunology-Host Defense and Epithelial Cell-Matrix Biology) and one clinical-translational
track (for further application to human disease). The basic tracks are designed to correspond to the major
themes of the pulmonary research program and to coincide with the graduate training program, and the clinical
track is aimed at extending these fields to human subject research and the Clinical Research Training Center
curriculum. This program structure allows for a broad-based faculty from 12 departments to coordinate and
focus research activities and trainee supervision in a multidisciplinary, collaborative, and synergistic process.
For all trainee activities within this structure, there is also a carefully constructed mentoring process that
includes benchmarks for individual trainee presentation, publication, and grant application. To achieve these
goals, all predoctoral and postdoctoral trainees engage in the same research review process that is home-
based around a joint Pulmonary Research Conference. This Conference is the hub for input from an overall
Program Review Committee (that includes the Program Director and his advisors) and a project-specific
Advisory Committee (that includes the trainee's mentors, co-mentors, and collaborators). Trainees also receive
input via individual lab and group meetings as well as additional research conferences that are set up to
coordinate with the research themes of the Program. The research-intense experience is supplemented
through graduate coursework to build general skills and specific knowledge of a research field. In addition,
there are mechanisms for mentors and trainees to achieve success in mentoring and diversity attributes of the
program. Together, these mechanisms serve to ensure high-level multidisciplinary trainee experiences and
performance in previous and present cycles of this longstanding and highly successful Program.

Public health relevance
Project Narrative Respiratory disease represents a major health care problem. Indeed, chronic lower respiratory (lung) disease is the third leading cause of death in the U.S. population. The purpose of our pulmonary research training program is to develop new leaders and innovators to drive research and development in the field of lung biology and disease and thereby solve this problem.